BabyStrong II (Stimulating the Tragus for Neural Growth): A Randomized Controlled Trial of taVNS-Paired Bottle Feeding to Improve Oral Feeding

Project Summary
The long-term goal of this project proposal is to develop and commercialize a therapy to assist pre-term and
term infants with brain injury overcome difficulties in learning to feed. Independent feeding is critical for infants
to be discharged home with their families and avoid placemen of a gastrostomy tube (G-tube) for direct stomach
feeding. The current standard of care for infants with feeding difficulty involves early oromotor stimulation and
feeding practice with therapists who guide safe feeding. Few other therapies exist for infants who are not making
progress with feeding volumes at term age. Technologies currently on the market are used to stimulate early
sucking patterns at 31-32 weeks gestational age with a puff of air, but do not work to stimulate active feeding in
older infants. Other technology monitor parameters, such as suck amplitude, but no technologies actively
improve oral feeding in older infants whose main reason for continued hospitalization is feeding delays.
To tackle this problem, we took the novel approach of pairing a non-invasive transcutaneous auricular vagus
nerve stimulation (taVNS) stimulation with bottle feeding. In these first-in-infant open-label pilot studies 54% of
infants in discussions for G-tube placement for feeding delay, reached full feeds within 2 weeks, and even infants
who did not achieve full feeds improved their po feeding volumes. Further, infants who got to full feeds showed
stronger and more complex circuits associated with motor skills, suggesting neuroplasticity associated with the
activity of taVNS-paired with feeding.
During the phase I STTR award period, our team moved from a complex system of electronic pulse
generators and computers to a handheld taVNS device, and a slimmed down, custom ear electrode targeting
the auricular branch of the vagus nerve at the tragus. We customized and refined the taVNS unit operation and
worked with manufacturers to make it specifically fit the needs of our infants. We obtained advice and feedback
from our parent and therapist advisors in deciding on a product. With this compact set-up that is easier to use,
we are ready to test the BabySTrong feeding system in a multicenter, randomized, controlled, blinded trial to
show efficacy in improving the daily feeding volumes, the days to full oral feeds, the number of infants who avoid
G-tube placement and increased neuroplasticity in white matter circuits. If this groundbreaking new approach to
infant feeding is successful, we may impact length of stay and associated hospital costs, and address family and
care provider frustration inherent with continued hospitalizations for feeding delays. With positive results from
this phase II trial, we hope to move the vision of feeding delay treatment to one of taVNS facilitating activity-
dependent neuroplasticity and feeding competence. The findings from this proposal will support our FDA
application and commercialization plans for the BabySTrong system.

Public health relevance
Project Narrative Preterm and term infants with brain injury frequently have difficulty learning to feed by mouth and may benefit from transcutaneous vagus nerve stimulation (taVNS) paired with the motor activity of feeding to boost brain circuits involved with feeding. The proposed study will test a novel taVNS-paired bottle system in a blinded, randomized, controlled, multisite trial in infants who have reached term age and failed to learn to feed. The BabyStrong feeding system may improve oral feeding volumes and help avoid a long hospital stay while trying to feed or placement of a gastrostomy tube (G-tube) in order to be discharged home with their families.